Inflammation and Immunosuppression in Lung Cancer

DESCRIPTION (provided by applicant): Chronic inflammation and immunosupression contribute to lung cancer formation. The long-term goal of this application is to identify the molecular and cellular mechanisms that control inflammation-induced tumorigenesis. Myeloid-derived suppressor cells (MDSCs) play a critical role in this process. MDSCs suppress T cell proliferation/function to subvert immune surveillance and prevent the immune system from eliminating tumor cells. Neutral lipid-derived hormones and their downstream nuclear receptors are keys to controlling the inflammation-induced MDSC surge and tumorigenesis. LAL hydrolyzes cholesteryl ester and triglycerides to generate free cholesterol and free fatty acids. Indeed, ablation of the lal gene resulted in systemic increase of MDSCs and immunosuppression of T cell proliferation/function in LAL knockout (lal-/-) mice. A defect in myelopoiesis with increased myeloid progenitor cells was observed in the lal-/- bone marrow. Adaptive bone marrow transplantation between wild type and lal-/- mice showed that both cell autonomous and tissue microenvironments contributed to abnormal MDSC development and homeostasis during LAL deficiency. To identify the molecular mechanism that controls these events, peroxisome proliferator-activated receptor gamma (PPARγ) appears to be a strong candidate. This is because 1) PPARγ is an anti-inflammatory agent; 2) LAL-derived lipid metabolites serve as ligands to activate PPARγ; 3) PPARγ negatively regulates inflammatory molecules that are up-regulated in lal-/- mice; 4) PPARγ ligand treatment ameliorated inflammation and pathogenesis in lal-/- mice. The central hypothesis for the proposed studies is that the LAL/hormonal ligands/PPARγ axis in myeloid cells controls MDSCs development, homeostasis, immunosuppression and lung tumorigenesis. To test the central hypothesis and accomplish the goal of this application, two Specific Aims have been proposed. Aim 1 will test a working hypothesis that PPARγ ligands are required for balancing anti- and pro-inflammation cascades in vivo by regulating myelopoiesis, MDSC expansion and immunosuppression. This will be accomplished by reintroducing PPARγ ligands into lal-/- mice to rescue inflammatory and pathogenic phenotypes. Effect of PPARγ ligand treatment on Lewis lung carcinoma engrafted tumor growth and metastases in lal-/- mice will be investigated; Aim 2 will test a working hypothesis that PPARγ is required for balancing anti- and pro-inflammation cascades in vivo by regulating myelopoiesis, MDSC expansion and immunosuppression. This will be accomplished by overexpressing dnPPARγ in myeloid cells to inhibit the endogenous PPARγ function in c-fms-rtTA/(tetO)7-dnPPARγ bitransgenic mice to promote chronic inflammation and lung cancer. Since this model showed de novo tumorigenesis in the lung, bone marrow and MDSCs transplantation will be performed to test if MDSCs in this mouse model are directly responsible for tumorigenesis. Accomplishment of the proposed studies will elucidate the molecular mechanism by which the LAL/hormonal ligands/PPARγ axis controls anti-tumor adaptive immunity and pave the way for novel immunotherapy of lung cancer.

Public health relevance
Chronic inflammation and immunosupression contribute to lung cancer. This proposal will utilize knock-out and transgenic animal models to identify the molecular and cellular mechanisms that control inflammation-induced tumor immunosuppression. Accomplishment of the proposed studies will elucidate the functional role of the LAL/hormonal ligands/PPARγ axis in anti-tumor adaptive immunity and pave the way for novel immunotherapy of lung cancer.